Fluid Movement across Conjunctiva: Stimulation and Regulation

DESCRIPTION (provided by applicant): We have previously characterized the isolated rabbit conjunctiva as an epithelial model of Na absorption and CI secretion. Our hypothesis was that these transport mechanisms, by providing the driving forces for fluid movement across the tissue, could enable the conjunctiva to either absorb fluid from, or contribute fluid to, the aqueous layer of the tear film. This was demonstrated with direct experiments using the rabbit epithelium. Our current hypothesis is that the human conjunctiva may also possess transporters that enable it to absorb Na and secrete CI with the consequent fluid absorption or secretion. For this fluid flow to occur, the conjunctiva must have (as most fluid transporting epithelia do) water channels, which are usually different in the apical and basolateral domains. We thus propose to identify with biochemical and histochemical protocols, the electrolyte transporters and water channels (aquaporins) in the human conjunctiva relevant towards the movement of fluid flow across the epithelium. Because receptor-mediated responses are atypical in rabbit conjunctiva, assays similar to those in human will be done on murine and porcine tissues to determine the best model for fluid transport in the human conjunctiva. Since aquaporins (AQPs) play a crucial role in fluid transport, and our experiments have shown that anisotonic conditions and cAMP-elevating agents can modify water permeability, protocols to understand the regulation of water permeability in murine and porcine tissues will be implemented. Biochemical, histochemical and functional experiments will be conducted on mice, rat and pig conjunctivae. From the determination of the transporters, the AQPs, and the functional physiological experiments that can be done on the conjunctiva of the selected animal models, a theoretical model for the fluid movement across the human conjunctiva will be proposed. From these studies we expect to expand the understanding of the physiology of the mammalian conjunctival epithelium, and provide evidence that direct or receptor-mediated stimulation of ionic transport mechanisms will result in fluid secretion towards the tear film. These studies may provide the groundwork for the design of future treatment modalities for dry-eye syndromes.